Molecular and Cellular Regulation of Vascular Calcification

Project Summary
Inappropriate accumulation of calcium phosphate salts in cardiac valve and vasculature, also known as vascular
calcification (VC), is increased with age, specific genetic disorders, coronary artery disease, valve disease,
diabetes and chronic kidney disease. Calcification of these normally compliant organs has severe impacts on
hemodynamics and cardiovascular function due to increased stiffness and/or tendency to rupture. There are
currently no pharmacological therapies approved to directly prevent or treat VC despite the recognized
deleterious effects of calcification in blood vessels and valves. Over the last 20 years paradigm-shifting studies
have revealed some of the key genetic pathways, cell types and pathobiological processes that control the
initiation and progression of VC These studies indicate that rather than a degenerative, untreatable inevitability,
VC is a regulated and potentially modifiable process. The challenge is to understand which pathobiological
processes predominate under specific disease conditions, and the critical upstream and downstream signaling
pathways regulating them in order to identify biomarkers and target for therapeutic development. The overall
goal of my research is to generate new scientific knowledge regarding the pathobiological mechanisms at play
in diabetes and chronic kidney disease, highly prevalent diseases with extremely high risk for VC and its
complications. We will continue to use a human first approach to identify key risk factors that may play a
causative role in VC, and mechanistic studies in animal models, organoids, and cell culture experiments to
identify key signaling pathways involved. The proposed studies will facilitate identification of biomarkers,
therapeutic targets and therapies to treat this silent killer and improve human health.

Public health relevance
Project Narrative The abnormal deposition of bone-like mineral in the valve and vasculature, also known as vascular calcification (VC), increases with age, vascular and valvular disease, diabetes and chronic kidney disease (CKD). Calcification of these organs leads to loss of compliance, stiffening and increased tendency to rupture, contributing to declining cardiovascular function and heart failure. There are no drug therapies for VC. The proposed research provides a foundation for future translational and clinical studies aimed at identifying effective biomarkers and targets, as well as developing therapeutics to prevent and/or treat VC.